Evaluating additive effects of including canines in Regulating Together: A Group Treatment to Address Emotion Dysregulation in youth with autism spectrum disorder

Project Summary/Abstract
The primary objective of this R01 application is to evaluate the potential additive effect of animal-assisted
intervention (AAI) on a manualized behavioral treatment targeting emotion dysregulation (ED) in children with
autism spectrum disorder (ASD). ED in youth with ASD has been linked to significantly higher rates of psychiatric
hospitalizations, suicidal ideation, use of psychotropic medications, school disciplinary actions, peer rejection,
failed college and employment transitions, and poorer quality of life. Our group developed Regulating Together
(RT), an intensive group-based treatment with a concurrent parent group that employs evidence-based
intervention techniques of cognitive behavioral therapy, parent training, and mindfulness and acceptance-based
therapy. Preliminary evidence for its feasibility and efficacy has been demonstrated, including reductions in
emotional reactivity and dysphoria and increases in heart rate variability and cognitive flexibility at 10-weeks
following intervention. Despite this, change did not occur immediately post intervention. Animal Assisted
Interventions (AAI) have emerged as a promising approach for youth with ASD, demonstrating improvements in
irritability, hyperactivity, positive affect, and quality of life. AAI also has shown to increase in-session engagement
and learning. Yet, AAI has not yet been utilized to systematically target ED in ASD nor has it been examined in
conjunction with a manualized intervention.
In the current study, we propose a multi-site randomized clinical trial of RT with and without a canine
present to evaluate its immediate and longer-term efficacy. In 240 youth (ages 8-12 years) with ASD, we will
assess RT with AAI (RT-Canine) and without AAI (RT-Standard) on primary ED symptom of reactivity, and
secondary outcomes, including dysphoria, caregiver stress, cognitive flexibility, mindfulness awareness, and
emotion regulation skills knowledge. We hypothesize that the canines will increase therapeutic engagement
measured through alliance, motivation, and improved behavior, which will then increase intervention session
level learning, and ultimately immediate and long-term intervention outcomes. Furthermore, based on our
preliminary evidence, we also will explore an objective outcomes measure of heart rate/heart rate variability and
its relationship to engagement, learning, and ED symptom outcomes.
This proposal is relevant to the NICHD Human-Animal Interaction funding opportunity by addressing the
critical public health issue of ASD through examination of AAI efficacy by utilizing standardized data collection
outcome methods. In addition, we closely address protection for both the canines and the youth with ASD
throughout the proposal. Finally, we will make a concerted effort to include youth from minority groups, as
emphasized in the FOA. Ultimately, findings from our study have the potential to expand both ASD and AAI
research, with immense impact on the well-being and outcomes of youth with ASD as evidence-based
interventions for ED in this population is a critical gap in mental health care.

Public health relevance
Project Narrative For youth with autism spectrum disorder (ASD), emotion dysregulation (ED) has emerged as a critical area of concern, one that leads to significant negative outcomes across the lifespan, and for which few evidence based interventions exist outside of our manualized program Regulating Together (RT), an intensive outpatient program for children with ASD+ED. Animal Assisted Interventions with canines have been found to increase engagement, therapeutic alliance, satisfaction, and attention when paired with psychological interventions. In the current proposal, we seek to evaluate the potential additive effects of canine assisted therapy paired with RT in a randomized controlled trial, utilizing a multi-method assessment battery including reactivity, dysphoria, cognitive flexibility, and heart rate variability, all of which we have already demonstrated feasibility and efficacy with the ASD population in past trials, as well as session level engagement and learning to further understand the role canines have during the intervention.